PREcision Care In Cardiac ArrEst - ICECAP (PRECICECAP)

Project Summary:
The PREcision Care In Cardiac ArrEst - ICECAP (PRECICECAP) parent R01 study aims to discover
novel biomarker signatures after cardiac arrest that predict treatment responsiveness and long-term
recovery. Cardiac arrest is a major public health problem and top cause of morbidity and mortality
nationally. Improving survival and functional recovery is of critical importance. We hypothesize that
through innovative, multi-parametric data driven approaches we will be able to identify distinct
clinically relevant subgroups of patients. Our primary analytical plan allows us to achieve our aims but
is not readily generalizable or usable by others. An ever-growing number of NIH-funded projects
amass and analyze similar datasets and develop their own custom solutions. This ad hoc approach is
costly, inefficient, and threatens both rigor and reproducibility. The objective of this supplement to
PRECICECAP is to complete a publicly available software platform that allows end-to-end curation of
complex neurocritical care data to create artificial intelligence/machine learning (AI/ML) ready
analytical datasets from raw waveform data. Building on our previous work, we will address the
remaining gaps needed to achieve this goal by: 1) developing standard processes to ensure data
quality, segmentation, and sampling; 2) feature engineering; and, 3) external validation of our entire
pipeline. This work aligns with and supports NIH goals for modernizing the biomedical research data
ecosystem by developing a software product that can handle AI/ML on this type of complex data. It
will also allow the sharing of a finalized analytical data set for use by others. By continuing our proven
collaboration between clinician investigators, data scientists and industry, we will take NIH-supported
data from the PRECICECAP study and make it broadly available and easily usable. The project
delivers an important software tool that can be used by others conducting similar research, advancing
the NIH’s mission to make complex data FAIR (Findable, Accessible, Interoperable, and Reusable).
The result will facilitate an open, wide collaboration between scientists, using similar data.

Public health relevance
Project Narrative: Patients with severe acute brain injury require intensive care where the brain, heart, lungs, and other organs are continuously monitored to guide treatments to reduce death and disability. The data generated from this monitoring are complex and contain rich information. This project will develop publicly available software tools to facilitate reproducible curation of AI/ML ready data and a large ready-to-analyze dataset from patients resuscitated from cardiac arrest, which together will have a major impact on public health by advancing efforts towards data-driven precision medicine.